Advanced wavefront shaping for imaging through ocular opacities

ABSTRACT
Optical technologies have become standard of care to assess the health of the posterior segment of the eye as
they offer the highest spatial resolution among available clinical tools. However, the performances of optical
imaging techniques quickly degrade in the presence of ocular opacities. Ocular opacities are widely occurring in
both the lens and the cornea, which leaves several patient populations and/or clinical scenarios where posterior
segment imaging is not available leading to a heightened risk of blindness due to undiagnosed retinal pathology.
This proposal explores a novel approach to this open issue, i.e. all-optical characterization and correction of
ocular opacifications with the goal of demonstrating high-resolution fundus imaging behind ocular opacities. Our
central hypothesis is that ocular opacities, like other turbid media, degrade vision through scattering, which can
be understood as a severe form of optical aberration, i.e. it can equivalently be mathematically described as a
linear transformation and as such it can be corrected via advanced forms of wavefront shaping. Our research
program is strongly founded on the tremendous growth of the field of imaging through turbid media (e.g. fog,
clouds, screens), a field in which the two PIs are established experts and have reported cutting-edge advances.
In proof-of-principle preliminary data, we have recently demonstrated Neural-network based Wavefront Shaping
(NWS) in turbid media such as screens and biological tissue with superior performances to any comparable
methods. Thus, our objective for this proposal is to demonstrate that NWS achieves optical correction of ocular
opacities and to establish what optical performances and specifications are required as well as feasible to
achieve high-resolution fundus imaging within the clinical ophthalmology settings. Our investigation will also
enable establishing correction requirements and assessing improved performance potential of other modalities
such as scanning laser ophthalmoscopy, fluorescence imaging, angiography as well as optical coherence
tomography.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal will develop and validate a new optical imaging modality to image the posterior segment of the eye in the presence of ocular opacities. This will provide a new clinical tool to provide retinal care to people for which no optical imaging tests are currently available. Ultimately, this imaging technique will improve the planning of cataract surgery as well as the diagnosis and management of macular diseases and glaucoma.